ROLE OF THE HUMAN KIDNEY IN GLUCONEOGENESIS AND PROTEIN METABOLISM

The overall goal of this project is to extend our knowledge of the regulation of glucose production in humans and to improve our understanding of the role of glutamine in human substrate metabolism.